Initiation and maintenance of Th17 inflammation in EKC syndrome

Epidermal differentiation disorders (EDD, a.k.a. the ichthyoses) are caused by pathogenic variants in over 50
genes and feature generalized skin scaling, thickening, and redness often associated with itch, a clinical marker
of inflammation. Prior work provides evidence of T helper (Th) 17 inflammation across EDD with an immune
signature resembling the common inflammatory skin disease psoriasis. Despite this, clinical response to Th17
inhibition has generally been poor or incomplete. Our lab discovered a novel genetic EDD, the
erythrokeratodermia cardiomyopathy (EKC) syndrome which results from heterozygous genetic variants
affecting the SR6 domain of desmoplakin. EKC features early childhood onset of inflammatory skin lesions and
progressive dilated cardiomyopathy. In contrast to the majority of individuals with EDD due to other genetic
causes, individuals with EKC have shown consistent and profound improvement in skin redness, inflammation
and, sometimes, cardiac function, when treated with therapies inhibiting the Th17 pathway, suggesting that
inflammation contributes to disease pathogenesis. We propose that EKC can serve as a model for Th17
inflammation due to genetic defects in skin barrier dysfunction, and our preliminary data shows increased innate
immune activity in EKC skin and keratinocytes expressing DSP variants. We have developed unique resources
that make us well-posed to study this phenomenon: skin tissue and primary cultured keratinocytes from
individuals with EKC, keratinocytes engineered to stably express EKC-associated DSP variants, and a
transgenic knock-in mouse model which allows us to express EKC-associated DSP variants across the entire
organism or specifically in skin. We will interrogate effects on desmosomes by assessing desmoplakin molecular
turnover at the cell membrane and structure and function of desmosomes using electron microscopy and
dispase-based mechanical dissociation assays. In addition, we will use unbiased transcriptomic profiling to
uncover cell-intrinsic innate immune signatures in cultured keratinocytes and molecular cross-talk between
keratinocytes, immune cells, and stromal cells in murine skin using single cell RNA sequencing. We generated
a transgenic knock-in mouse model of EKC with skin-specific expression of mutant Dsp driven by Keratin14-Cre
and found that K14-DspL622P/WT mice are viable with intact barrier at birth, mirroring EKC patient presentation.
Over time, K14-DspL622P/WT mice develop progressive inflammatory lesions and elevated markers of Th17
immunity, establishes the utility of this model to study Th17 inflammation due to skin barrier dysfunction. We will
use flow cytometric analysis of skin tissue and plasma cytokine profiling to assess inflammatory markers in the
mouse model and test how modulating the cutaneous microbiome (through both depletion and diversification of
skin microbes) affects markers of Th17 inflammation. Studying the cellular determinants of innate immune
activation and specific cellular interactions which drive initiation and maintenance of Th17 inflammation in EKC
may elucidate mechanism underlying the pattern of Th17 polarization that is shared across EDD.

Public health relevance
PROJECT NARRATIVE Despite evidence of a shared T helper (Th) 17 signature across genetic epidermal differentiation disorders (EDD, a.k.a. ichthyoses), generally poor or incomplete clinical responses to Th17 inhibition have been observed. The pathobiology of Th17 polarization in EDD remains poorly understood, and there is significant opportunity to discover the role of keratinocytes in initiating inflammation, the cell types involved in contributing to inflammation, and the contribution of the cutaneous microbiome. This project utilizes the rare monogenic disease erythrokeratodermia cardiomyopathy (EKC) syndrome as a model to study initiation and maintenance of Th17 inflammation due to genetic defects in skin barrier function.